Newborn Iron Deficiency

ABSTRACT: Early-life iron deficiency (ID) is prevalent throughout the world, affecting 40-50% of pregnant
women, fetuses, and children. ID impairs cognition in children, causes persistent cognitive impairments and
increases risk of neuropsychiatric disorders despite postnatal iron treatment. The long-term effects of early-life
ID are the real cost to society because of lost education and job potential and their association with
transgenerational racial health disparities. In mice, hippocampal neuron-specific ID causes long-term
learning/memory neurocircuit dysfunction despite postnatal iron repletion, demonstrating the long-term effects
are due to neuronal iron loss during development. Thus, dysregulation of early-life neuronal iron-requiring
activities set neuronal functional capacity across the lifespan.
The fetal/neonatal brain is highly metabolic, accounting for 60% of total body oxygen consumption. The
hippocampus has one of the highest regional metabolic rates in the neonatal brain. Iron provides the catalytic
component for enzymes required for mitochondrial electron transport and energy production. Mitochondrial
quality control mechanisms (e.g., redox balance, fusion/fission, and mitophagy) maintain mitochondrial structure
and energetic homeostasis and prevent long-term mitochondrial damage and dysfunction. Early-life ID acutely
disrupts these processes, impairing dendrite and synapse formation. Postnatal iron repletion does not rescue
ID-induced mitochondrial energetic impairments in the adult brain, suggesting a permanent reprogramming.
The cellular mechanisms of how developmental ID causes long-term neuronal structural and functional
deficits and whether these can be prevented with iron treatment alone are unclear. We will test the overall
hypothesis that permanently impaired hippocampal mitochondrial energetic capacity and quality control is
programmed during early life, directly contributes to the compromised neurocircuitry that persists after recovery
from early-life ID and that prenatal maternal iron repletion is required to prevent this. In Aim 1, we will utilize a
unique in vitro model of chronic fetal-neonatal hippocampal neuronal ID to test the timing and dose of
iron repletion during development in order to prevent programming of long-term mitochondrial neuronal
structural deficits. We will treat iron-deficient hippocampal neuron cultures with moderate or high dose iron at
neuron developmental stages equivalent to human 2nd trimester, birth, and 6-12 months. Recovery of
mitochondrial quality control mechanisms and synapse formation will be assessed as outcome measures. Aim
2 uses an in vivo rat model of dietary fetal-neonatal ID to test whether fetal iron treatment is necessary
and sufficient to prevent permanent abnormalities in hippocampal mitochondrial structure/function,
epigenetics, neuron structure and neurocognitive behavior in adulthood. This proposal is highly significant
because it will provide neurobiologically-based mechanistic evidence to delineate accurate timing and dosing of
iron repletion and inform adjunct therapy strategies to reduce the lifelong consequences of fetal-neonatal ID.

Public health relevance
PUBLIC HEALTH RELEVANCE Iron deficiency is very common nationally and globally during fetal-neonatal life, causes significant neurobehavioral abnormalities in children (e.g., cognitive and psychosocial deficits), is not reliably prevented by iron treatment in early life, and results in significant costs to society stemming from lost education/job potential and increased later developing mental health problems. We propose to perform studies in primary neuron cell cultures and a dietary rat model of fetal-neonatal iron deficiency anemia to define the specific role of iron treatment timing and dose in programming brain mitochondrial function and rescuing or exacerbating the long- term neurobehavioral effects caused by early-life ID. Successful completion of these studies will a) identify a critical period during pregnancy or early infancy when iron treatment is effective, b) provide mechanistic insights into how early life iron nutrition programs brain mitochondrial functional capacity across the lifespan and c) provide a biological foundation for the need for early-life biomarkers of brain iron status to prevent long-term dysfunction.